Ola HAWAII

PROJECT SUMMARY/ABSTRACT
With continued support from the National Institute on Minority Health and Health Disparities (NIMHD) through
the RCMI U54 RFA-MD-22-002, the goal of Ola HAWAII is to improve minority health and reduce health
disparities for those communities in Hawaii which suffer disproportionately in health outcomes and healthcare
access. In the next five years, the objective of the Center is to lead and advance minority health and health
disparities research in Hawaii. Ola means “health” and “to heal” in Hawaiian and HAWAII designates both our
island homeland and our aspiration “Health And Wellness Achieved by Impacting Inequalities”.
Specific Aim 1: Enhance institutional capacity to facilitate basic biomedical, clinical and behavioral
research.
a. Manage, coordinate and supervise Ola HAWAII activities and resource allocation.
b. Develop and institute a plan for the dissemination of research findings, including health policy development
through UHealthy Hawaii.
c. Implement a rigorous evaluation process for continuous improvement.
Specific Aim 2: Address health disparities and health-related concerns of underserved communities.
a. Nurture trust-based collaborations with communities through capacity building and resource sharing to
address community-identified, health-related concerns.
b. Promote and facilitate community participation in all aspects of health disparities research, including
dissemination of research outcomes to community, academic, and policy partners.
Specific Aim 3: Mentor and support a diversified health disparities research workforce.
a. Customize and expand the Pilot Projects Program to support post-doctoral fellows, junior faculty, and
other early-stage investigators.
b. Personalize and enrich the Mentoring Bootcamp Program to accelerate lead investigator research success.
Specific Aim 4: Enhance the quality and productivity of health disparities and health-related research
through world-class research facilities and services.
a. Strengthen and sustain core facilities and resources.
b. Expand and diversify core user base, capability, and reach.
c. Implement a personalized Research Studio Program.
Ola HAWAII will continue to be led by the MPI team of Jerris R. Hedges, MD, and Noreen Mokuau, DSW, who
will work closely with an exemplary team to achieve the aims. By building on its successes and integrating
innovative new approaches, Ola HAWAII will have a profound impact on health disparities research in Hawaii.

Public health relevance
PROJECT NARRATIVE The long-term goal of the RCMI Specialized Center, Ola HAWAII, is to improve minority health and reduce health disparities for those communities in Hawaii which suffer disproportionately in health outcomes and healthcare access. In the next five years, the objective of the Center is to lead and advance minority health and health disparities research in Hawaii. Ola HAWAII has assembled an exemplary team to build institutional capacity in basic biomedical, clinical and behavioral research; engage underserved communities; mentor and support a diversified workforce; and enhance core facilities and resources.